Gene expression in amphibian development

ABSTRACT
Our goal is to understand early vertebrate development at the molecular level. We study the problem in the
frog Xenopus, whose abundant eggs are large and readily manipulated by microinjection and microsurgery.
The eggs are large enough to produce material for biochemical analysis, and importantly for this project, ample
material from staged and manipulated embryos or explants for deep sequencing, or chromatin for
immunoprecipitation.
During previous grant periods, we have identified potent signaling and signal transduction activities that
contribute to embryonic development and neural induction. Recently we focused on formation of the posterior
region of the embryo, which is specified by Wnt and FGF signaling in the gastrula. In parallel we improved
genome assemblies and annotation for X. tropicalis and X. laevis, enabling a systems level approach. These
assemblies not provide the resources necessary for hypothesis driven research for the community, but also
delivered the surprising finding that after X. laevis became tetraploid through subspecies hybridization, gene
losses and gene expression evolved differently between the different progenitor genomes.
In the next grant period, we will determine how the Wnt and FGF pathways act on specific gene regulatory
elements, in combination or individually. We will characterize genes and enhancer elements that respond to
one or both signals, and test how they react to graded signals, or combinations and timing of signals, to
resolve how posterior pattern formation is mediated. While the effect of timing of signaling has been
documented, its contribution to the induction of distinct fates in the Anterior Posterior axis has not been
addressed.
In parallel work, we will move from the resource aspect of genome assembly to testing hypotheses on how
genomes respond to tatraploidy. We will construct new species hybrids and ask whether they activate a “hybrid
dysgenesis” program of transposon activation, and whether new transposition events occur selectively into one
progenitor genome, leading to selective gene loss on that genome. We will also explore the alternative
hypothesis that new chromatin marks selectively favor one genome for gene expression and gene retention
over the other progenitor genome.
The results of these experiments will provide basic understanding of normal vertebrate development and
evolution, and potentially the mechanisms by which birth defects, and diseases of aberrant signaling, such as
cancers, may arise.

Public health relevance
NARRATIVE Human diseases are frequently associated with aberrant function of genes normally used in early development. Here we will understand the regulation and function of gene products that act in the normal patterning of the early embryo, including signaling mediated by transcriptional regulators. In a second project, we will aim to understand how the vertebrate genome evolved after whole genome duplication to selectively retain subsets of duplicated genes.